Combatting AntiMicrobial Resistance in Africa Using Data Science (CAMRA)

Bacterial infections are highly prevalent and contribute significantly to morbidity and mortality
across all age-groups but because appropriate microbiologic diagnostic services are non-
existent or very limited, ascertaining the specific etiologic agents and the true prevalence of
antimicrobial resistance (AMR) is a major challenge in Africa, where objective data is limited.
Preliminary observations from Nigeria, the most populous country in Africa include the
following; a) High prevalence of Salmonella enterica serovar Typhi (S. Typhi) with 45%
prevalence of multidrug resistance, b) High prevalence of Extended Spectrum β-Lactamase-
producing Enterobacteriaceae (ESBL-E) blood stream infections, c) Maternal colonization by
ESBL-E in women at delivery is associated with high all-cause morbidity and mortality in their
newborn babies compared to ESBL-unexposed babies and d) Periodic outbreaks of
carbapenem-resistant Klebsiella pneumoniae sepsis in newborn units with case fatality rates as
high as 45%. We have preliminary molecular characterization of about 500 of the 2,750 diverse
bloodstream bacterial isolates in our collection. In addition, we have access to a collection of
over 2,500 clinical isolates of blood, sputum and urine from our sentinel laboratories in Nigeria
and Rwanda that are partially characterized. Our unique observations related to AMR genes
that we have identified in our archived isolates form the basis for this research proposal. Our
overall strategy in this application focuses on three thematic areas: 1). Comparative
phenotypic and genotypic studies of archived and contemporary clinical isolates to inform trends
in AMR and dynamics of transmission. 2) Incorporation of acute inflammatory markers of
serious bacterial infection and gene products from resistant bacteria into a portable screening
tool for clinical care and 3). Explore the potential benefit of an aminoglycoside (Tobramycin)
conjugated to an antimicrobial peptide for enhanced bactericidal activity against multi-drug
resistant enterobacteriales. We have assembled a multidisciplinary team of clinical and
molecular microbiologists, clinicians, biomedical engineers, environmental microbiologists,
veterinarians, and industrialists to implement this project in Nigeria, West Africa and also
Rwanda, East Africa to provide data with geographic representation for Africa. Upon successful
completion of this program, we would have utilized the data science platform for bacteria
genomics and antimicrobial resistance to raise awareness on the scope of AMR in Africa,
provide novel pathways for optimizing empiric use of antibiotics and trained a handful of young
African scientists in bacterial genomics and bioinformatics.

Public health relevance
This research is highly relevant to public health, especially in the U.S., because it investigates the global spread and genetic evolution of antimicrobial-resistant (AMR) bacteria, threats that can rapidly cross borders through travel and migration. By generating critical genomic data and advancing diagnostic and therapeutic tools in Africa, it enhances global AMR surveillance and informs strategies to prevent the emergence and spread of “superbugs” that pose a serious risk to U.S. healthcare systems.